Human Dopamine Grafts in Alpha-Synuclein Models of Parkinson Disease

ABSTRACT
Parkinson's disease (PD) is one of the most common neurodegenerative disorders. It is characterized by the
progressive loss of dopamine neurons in the substantia nigra (SN) pars compacta, and their projections onto
striatal neurons and the accumulation of α-Synuclein aggregates often into Lewy bodies. The pathogenesis of PD
is not fully elucidated but there is vast evidence supporting complex loops of neuroinflammatory cascades,
mitochondrial dysfunction, degenerating neurons, sustained microglial activation and other pathophysiological
mechanisms that together amplify a relentless progression towards neuronal loss in the nigra and beyond. α-
Synuclein (α-S) aggregates are implicated either directly in serving as a template that is transmitted
transneuronally and seeding further aggregation, and/or in amplifying the neuroinflammatory loop, leading in
both cases to neuronal dysfunction and death. To date, there are no therapeutic options that lead to the
regeneration of lost neurons or to the restoration of circuitry. Our group has pioneered the derivation of
functional dopamine neurons from human embryonic stem cells (hES) and we have just completed a Phase 1
clinical trial for the bilateral intrastriatal grafting of these cells. There is much excitement about the restorative
potential of stem cell derived neurons in PD, but there remain multiple challenges. Here we propose to study the
impact of microenvironmental alterations in the brain in the context of 2 different mouse models: the 3K mouse
model which expresses a triple mutant form of α-synuclein based on the human E46K mutation, and exhibits
histological hallmarks of PD as well as progressive motor and other behavioral abnormalities; the second model
consists of the intrastriatal injection of preformed α-synuclein fibrils (PFF) which spread transneuronally
through the brain to form pathogenic α-synuclein inclusions, leading to loss of DA neurons and behavioral
deterioration. These models are predicated on two different hypotheses and will serve as great tools to study
inflammation and its impact on behavior. In addition, we will graft the mice with the same hES cell derived
dopamine neurons used in the clinical trial to analyze the impact of the microenvironment on the neurons'
survival and phenotype, as well as on their ability to rescue behavior. We will capture grafted cells as well as host
microglia and astrocytes at key timepoints during the in vivo lifespan of the grafts to establish dynamic maps of
cell lineages, maturation, microglial and astrocytic phenotypes and potentially activation of neurotoxic signals.
In the last aim, we will engineer the human ES cells to delete the SNCA gene encoding α-synuclein in an attempt
at increasing the resistance of the grafts to neurotoxicity and potentially the transmission of pathogenic α-
synuclein. Data obtained in this proposal will serve to further enhance our understanding of neuro-inflammation
in different PD microenvironments and could result in enhanced strategies for cell grafting including the use of
gene edited cells that are resistant to neuroinflammation.

Public health relevance
PROJECT NARRATIVE There is great enthusiasm about the regenerative potential of grafting dopamine neurons derived from stem cells into the brains of patients with Parkinson's disease (PD). But there are concerns about the negative impact of the abnormal proteins and inflammation in the Parkinson brain on graft survival. Here we analyze inflammation in brain cells and in human grafts injected into the brain of α-synuclein mouse models of PD; we also develop gene editing methods to enhance the resistance of graft cells to neurotoxicity due to inflammation.